Enhancing antigen-based therapy for T1D by T cell coreceptor tuning

SUMMARY/ABSTRACT
Currently no cure exists for Type 1 diabetes (T1D). Due to immune-mediated destruction of the insulin-
producing  cells, treatment of T1D is limited to daily exogenous insulin administration. Needed are
immunotherapies that effectively suppress  cell autoimmunity longterm in order to prevent and treat T1D. One
approach is the administration of cell autoantigens to induce differentiation of adaptive regulatory CD4+ T
cells (aTreg). The approach is appealing since autoimmunity can be selectively targeted while leaving acquired
immunity unperturbed. A major hurdle, however, is inducing a sufficiently sized and subset diverse aTreg pool,
while avoiding expansion of pathogenic effector T cells (Teff). The size and nature of the aTreg pool is
particularly important at late preclinical T1D stages and at the onset of clinical diabetes, when a high frequency
of diabetogenic CD4+ and CD8+ Teff is found. This R21 outlines a novel approach to enhance the efficacy of
antigen therapy by “tuning” the function of CD4. CD4 binding to MHCII activates a signaling cascade that
contributes to overall TCR signaling strength. We hypothesize that modulating CD4 function and TCR signaling
strength, results in increased and selective induction of aTreg by antigen vaccination. In our model,
differentiation of aTreg subsets is determined by varying the level of coreceptor tuning (CoT). We will employ
nondepleting CD4 antibody to achieve CoT. Key objectives of this R21 are to gain initial insight into the
mechanism(s) by which CoT selectively promotes aTreg differentiation (Aim 1), and determine the therapeutic
efficacy of this combinatorial approach (Aim 2). If successful, combined CoT and self-antigen vaccination is
expected to be applicable not only for the prevention and treatment of T1D, but also for other T cell-mediated
autoimmune diseases and pathologies.

Public health relevance
NARRATIVE The goal of this work is to provide proof-of-concept that coreceptor tuning enhances the therapeutic efficacy and safety of antigen-based immunotherapy for the purpose of suppressing ongoing T cell-mediated autoimmunity long-term.